Investigating Neuroprotective Roles of BCAT1 During Hypoxia

PROJECT SUMMARY:
Hypoxic ischemic encephalopathy (HIE) is a developmental brain injury caused by transient reductions in oxygen
supply to the term fetus. HIE is a significant cause of neurodevelopmental disorders like autism and epilepsy,
suggesting that prenatal hypoxia exposure can cause lifelong neurological dysfunction. The underlying molecular
mechanism(s) are not well understood, but an emerging hypothesis suggests that disruptions to epigenetics
during prenatal hypoxia may be causal to neurodevelopmental phenotypes. Notably, hypoxia’s effect on cellular
metabolism influences pools of metabolite precursors for epigenetic marks, highlighting the importance of
investigating the metabolic-epigenetic axis of perinatal hypoxic brain injury. A paradigm of mild prenatal hypoxia
demonstrated the upregulation of all three branched chain amino acids (BCAAs), leucine, isoleucine, and valine,
in fetal mouse brain. Additionally, our analysis revealed that expression of branched chain amino acid
transaminase 1 (Bcat1), the enzyme that catalyzes the catabolism of the BCAAs, is also significantly upregulated
in almost all neuronal types by prenatal hypoxia. BCAT1 transaminates the BCAAs, in that it catalyzes the
reversible transfer of the amino group from the BCAAs to alpha-ketoglutarate (a-KG) to form glutamate and the
branched chain ketoacids (BCKAs). BCAA supplementation has recently emerged as a therapeutic for traumatic
brain injury, and thus understanding hypoxia’s influence on BCAA metabolism could reveal a critical role for
BCAT1 in neonatal hypoxic brain injury. Additionally, BCAT1 regulates the concentrations of glutamate, the
overproduction of which can induce neuronal injury during prolonged periods of hypoxia, and a-KG, which is an
essential cofactor for chromatin modifying enzymes. Moreover, accumulating evidence suggests BCAT1 may
play a role in reducing oxidative stress in multiple cell types, making it an appealing potential neuroprotective
target for studies of neonatal hypoxic brain injury. I hypothesize that BCAT1 plays a neuroprotective role
during hypoxia by modulating histone methylation and reactive oxygen species (ROS) in neurons. In this
proposed set of aims, I will address this hypothesis utilizing neurons differentiated from human induced
pluripotent stem cells (hiPSCs) and primary mouse neurons to assess BCAT1’s impact on BCAA metabolism,
epigenetics and oxidative stress during hypoxia. In Aim 1, I will use stable isotope tracing and steady state amino
acid measurement by liquid chromatography-mass spectrometry (LC-MS) to define hypoxia’s effect on neuronal
BCAA metabolism. Additionally, I will use Cleavage Under Targets and Tagmentation (CUT&Tag) and bulk
mRNA-sequencing (RNA-seq) to profile BCAT1’s impact on histone methylation and gene expression during
hypoxia. In Aim 2, I will test potential mechanisms of neuroprotection by measuring ROS, cell viability, and
neuronal morphology in BCAT1-/- neurons exposed to hypoxia. Characterizing hypoxia’s influence on BCAT1
regulation of BCAA metabolism, epigenetics, and oxidative stress is crucial to evaluating the potential for BCAA
supplementation or restriction as a novel therapeutic.

Public health relevance
PROJECT NARRATIVE: Preliminary work from our group has revealed that neuronal BCAA metabolism is disrupted by prenatal hypoxia. This project aims to characterize hypoxia’s effects on BCAA metabolism, epigenetic signatures, and oxidative stress, focusing on the role of branched chain amino acid transaminase 1 (BCAT1). Elucidating the function of BCAT1 in the neuronal hypoxic response will provide insights into the role of BCAA metabolism in the cellular hypoxic response and will provide crucial insight into the therapeutic potential for supplementation or restriction of BCAA content in infant formula for prenatal hypoxia.